Pharmacophore - Directed Retrosynthesis Applied to Bioactive Natural Products Informing Mechanism of Action Studies

Project Summary/Abstract
Our proposed studies of the chemistry and biology of natural products (NPs) that possess anticancer,
immunosuppressive, anti-ischemic, and antibacterial effects are guided by the following inquiry: Can natural
product total synthesis be more closely aligned with simultaneous biological studies by targeting designed,
simplified derivatives, that each possess a proposed pharmacophore, during the retrosynthetic planning
stages? This tactic, which begins with a hypothesis for a natural product’s ‘pharmacophore,’ enables collection
of structure-activity relationship (SAR) data throughout a total synthesis effort enabling early discovery of
simplified bioactive derivatives. Building on Wender’s call for function-oriented synthesis, this variation of
retrosynthetic analysis, seeks to more closely align total synthesis efforts with concurrent biological studies
and opens the potential to identify simplified versions of the natural product with similar potency or even new
functions in the course of a total synthesis effort. We call this strategy ‘pharmacophore-directed retrosynthesis’
(PDR) to emphasize the importance of incorporating hypothesized pharmacophores into the retrosynthetic
planning stages of a total synthesis effort. This approach has the potential to greatly accelerate harvesting the
rich information content of NPs which historically has had immense impact on basic cell biology and medicine.
Our strategy begins with a hypothesized pharmacophore, based on available SAR data, and this directs the
retrosynthetic analysis. Stepwise, methodical introduction of structural complexity to this pharmacophore en
route to the natural product enables concurrent collection of SAR data which informs probe synthesis useful
for cellular target identification by our diverse group of ongoing collaborators employing biochemical,
proteomic, and genetic approaches. We anticipate that our proposed research will continue to contribute to
basic cell biology while also identifying new chemotypes for next generation small molecule therapeutics.
Several NPs to be studied are proposed to engage protein targets covalently, thus this research will contribute
to the re-emerging topic of covalent drugs.
In the last grant period, a total synthesis of rameswaralide revealed the anticancer effects of a simple
bicyclic b-ketoester. In addition, a synthetic intermediate, that was found to exhibit greater activity than the
natural product, is showing potential as a new inhibitor chemotype for a poorly understood kinase. Several
additional simplified derivatives of NPs, bearing a proposed pharmacophore, were synthesized and exhibited
bioactivity. In the next grant period, we will fully develop a variant of PDR that targets alkynes as both synthetic
intermediates and proteomic probes that may be more generally applicable. Inspired in some cases by our
PDR approach, we are developing novel synthetic strategies including late-stage functionalizations of
macrocycles reminiscent of biosynthetic tailoring enzymes, intramolecular directed CH oxidations and Diels-
Alder reactions, tandem [2+2]/Grob-fragmentation reactions, and novel couplings with diborylated alkenes.

Public health relevance
Project Narrative The proposed studies will open new avenues for small molecule-based therapeutic intervention against cancer, inflammation, stroke, and infectious disease. The natural products and designed, simplified derivatives to be synthesized en route to the natural product, become potential drug-leads while derived cellular probes will enable identification of novel therapeutic targets that will impact the treatment of human disease. Overall, the identification of novel small molecule-protein interactions is critical for the development of the next generation of human therapeutics and the proposed research will contribute significantly to this area.